Defining the molecular basis of thrombospondin-1-induced fibro-fatty diaphragm remodeling--a driver of obesity-associated respiratory dysfunction

ABSTRACT
Breathing disorders affect most individuals with obesity—and while respiratory muscle dysfunction occurs with
elevated BMI, its underlying pathophysiology and potential therapeutic targeting in obesity-associated pulmonary
compromise are largely uninvestigated. Mice subjected to diet-induced obesity (DIO), develop diaphragm
weakness. In these animals, intra-diaphragmatic adiposity, and extracellular matrix (ECM) content quantitatively
correlate with reductions in muscle contractile force. Resident mesenchymal cells called fibro-adipogenic
progenitors (FAPs) are the source of all adipocytes and many ECM-depositing cells in the obese diaphragm.
With DIO, diaphragm FAPs assume a proliferative, fibrogenic phenotype, and differentiate toward a Thy1-
expressing sub-population previously linked to muscle degeneration.
Thrombospondin-1 (THBS-1) is a matricellular protein produced by cell types including macrophages, adipocytes
and FAPs. Physiologically induced by injury and ischemia, THBS1 levels chronically increase in obesity. A FAP
mitogen and activator of TGF signaling, THBS-1 has been linked to fibrotic and degenerative changes in genetic
myopathies. Global Thbs1 knockout subjected to DIO gain equivalent weight to WT controls, but do not exhibit
FAP pool expansion or shift toward the Thy-1 expressing sub-type. Moreover, Thbs1-null diaphragms are
protected from obesity-induced increases in adiposity and ECM deposition. Strikingly, Thbs1 knockout mice
maintain normal diaphragm contractile force and motion with DIO.
We hypothesize mesenchymal THBS1 promotes TGF-mediated, FAP-driven stromal expansion that can be
targeted to mitigate diaphragm weakness and respiratory dysfunction in obesity. We will test the hypothesis
through cell and tissue-based systems, in genetically engineered mouse models, and in human subjects: (1)
First, we will employ primary cell culture to interrogate TGF and other putative THBS1 effectors as drivers of
FAP proliferation, fibrogenesis and adipogenesis. We will then leverage a FAP-myobundle organoid system to
determine whether the negative impact of THBS1 on muscle contractile function depends on FAPs. (2) Next,
we will apply mouse models of inducible cell type-specific Thbs1 ablation (macrophage, adipocyte, FAP) to
establish the cellular source of pathogenic THBS1 in obesity. We will also treat DIO mice with agents targeting
THBS1/TGF-driven fibrosis to test whether this maneuver is sufficient to forestall or reverse pathological
diaphragm remodeling and respiratory dysfunction. (3) Finally, we will analyze a translational weight loss cohort
to define the relationship among circulating THBS1 levels, diaphragm motion (ultrasound measurement of
diaphragm excursion amplitude), and diaphragm fibro-adipogenic remodeling (ultrasound measurement of
muscle echo intensity). Together, the proposed experiments will define targetable cellular and molecular
mechanisms underlying obesity-induced respiratory dysfunction.

Public health relevance
PROJECT NARRATIVE Respiratory dysfunction is a common and debilitating complication in individuals with elevated BMI. The current proposal evaluates the molecular mechanism by which thrombospondin-1 (THBS1), an obesity-associated matricellular protein, negatively impacts diaphragm structure and function to impair respiration in obese mice. Further studies in human subjects determine how obesity-specific THBS1 levels correspond with pathogenic muscle remodeling and respiratory compromise.